Circulating tumor DNA guided de-escalation of frontline diffuse large B-cell lymphoma therapy

PROJECT SUMMARY
The treatment paradigm for newly diagnosed diffuse large B-cell lymphoma (DLBCL) has largely
remained unchanged: a uniformly applied regimen of 6 cycles of rituximab with cyclophosphamide, doxorubicin,
vincristine, and prednisone (R-CHOP). A newer regimen for intermediate or high-risk patients replacing
vincristine with polatuzumab vedotin (R-pola-CHP) has recently shown improved efficacy. The randomized
FLYER study demonstrated that shortening frontline therapy for patients younger than 60 with limited-stage, low-
risk DLBCL from 6 cycles of R-CHOP to 4 cycles of R-CHOP followed by 2 cycles of rituximab alone is possible
with equal efficacy and decreased toxicity. However, eligibility for this approach is based on a pre-treatment risk
assessment applicable to a minority of patients. Stratifying a patient with advanced stage DLBCL as low risk by
their interim response could be a new way to identify patients for treatment de-escalation.
Fragments of circulating tumor DNA (ctDNA) containing cancer-specific sequences can be isolated from
patient peripheral blood. Next generation sequencing-based assays that detect ctDNA have shown promise as
“liquid biopsies” in DLBCL, allowing for molecular response assessment and detection of minimal residual
disease (MRD). However, this technology has not yet been used in real-time. All studies on ctDNA in DLBCL
have been retrospective or non-interventional to this date, involving sequencing of archival samples without
clinical integration. Phased variant enrichment and detection sequencing (PhasED-seq), which involves the
detection of fragments of ctDNA harboring multiple somatic mutations, boasts the lowest limit of detection of
available techniques. In retrospective and prospective analyses, patients who were MRD negative by PhaED-
seq after 2-3 cycles of frontline DLBCL therapy experienced long term remissions in >90% of cases.
Patients with advanced stage DLBCL that achieve interim MRD-negativity are likely overtreated with 6
full cycles of therapy, and a ctDNA-guided de-escalation approach could still lead to cure while sparing patients
from unnecessary toxicity and treatment. Demonstrating the feasibility of real-time ctDNA sequencing during
DLBCL therapy is needed before adopting said approach into routine clinical practice. Our central hypothesis is
it is feasible to perform interim ctDNA sequencing during standard frontline DLBCL therapy to determine which
patients should discontinue chemotherapy early. The proposed single-center pilot study will enroll 8 patients with
newly diagnosed, stage II-IV DLBCL intended for 6 cycles of R-CHOP or R-pola-CHP. Patients MRD-negative
by PhaED-seq after cycles 2 and 3 will de-escalate to rituximab alone for cycles 5-6, while all other patients will
receive 6 full cycles. We will investigate the following aims: 1. Determine the feasibility of ctDNA assessment in
real-time to guide decision making during frontline therapy for DLBCL, 2. Assess the outcomes of patients who
become undetectable for ctDNA during frontline therapy for DLBCL and discontinue chemotherapy early, and 3.
Evaluate the safety profile associated with a de-escalated course of frontline therapy for DLBCL.

Public health relevance
PROJECT NARRATIVE It is not known whether it is feasible to perform circulating tumor DNA (ctDNA) sequencing in real-time to guide treatment decisions during therapy for newly diagnosed diffuse large B-cell lymphoma. Patients who achieve an excellent interim ctDNA-defined response during frontline treatment experience high cure rates and can likely receive an abbreviated chemotherapy course with decreased toxicity and without compromising outcomes. This response-adapted approach, if feasible, can subsequently evaluated in a larger randomized study, as well as applied to escalation strategies for patients with suboptimal interim ctDNA-defined response.